Hepatic Integration of Mitochondrial Oxidative Metabolism Pathways in Health and Disease

Non-alcoholic fatty liver disease (NAFLD), including non-alcoholic steatohepatitis (NASH), is the most common
liver disease in the United States and it increases the risk for cirrhosis and hepatocellular carcinoma. Prior
research shows that dysregulated lipid partitioning in liver mitochondrial oxidative metabolism pathways [i.e.,
tricarboxylic acid (TCA) cycle, oxidative phosphorylation (OXPHOS), and ketogenesis] is fundamental to liver
steatosis and oxidative stress that underlie NAFLD. A traditional view of mitochondrial lipid partitioning is that
lipids are fated to ketogenesis when the capacity of terminal oxidation (TCA cycle and OXPHOS) is exceeded,
but ketogenesis is limited when the TCA cycle and OXPHOS can support terminal oxidation or under states of
high hepatic energy demand. However, this dualist view of lipid partitioning fails to describe heterogeneity in
mitochondrial function across the NAFLD spectrum and reveals knowledge gaps in our understanding of how
liver mitochondria may coordinate lipid catabolism. The objective of this project is to test the innovate premise
that ketogenesis actively supports TCA cycle function and that loss of this salutary coupling contributes to
NAFLD. This is based on our preliminary data from mouse models of varying NAFLD severity. Initial studies
used phosphatidylethanolamine N-methyltransferase (PEMT)-null mice that exhibit NASH owing to reduced
phosphatidylcholine, which is characteristic of human NASH. PEMT-null mice showed lower liver NAD+ and
molecular indices of terminal oxidation, however, in vivo TCA cycle flux was unaltered and ketogenesis was
increased. This phenotype in mice mimics our preliminary data in humans with NASH which showed elevated
ketogenesis and preserved TCA cycle flux. Notably, PEMT-null mice fed a high-fat diet and wild type mice fed
a ketogenic diet had lower liver nicotinamide N-methyltransferase (NNMT), which may lead to greater NAD+
salvage to facilitate TCA cycle flux that would otherwise be impaired. In addition, knockdown of ketogenic
enzyme 3-hydroxymethylglutaryl-CoA synthase 2 (HMGCS2) in mice on a high-fat diet resulted in lower liver
ketogenesis (as expected) and NAD+. Our central hypothesis is that ketogenesis enhances TCA cycle flux via
acute and chronic NAD+ provision under conditions of excess lipid availability. This hypothesis will be tested
via two Specific Aims. Aim 1 will demonstrate that a ketone body-NNMT-NAD+ axis mitigates liver steatosis by
promoting TCA cycle flux in NASH. Mice lacking liver HMGCS2 will receive a Gubra Amylin NASH (GAN) diet
and will be independently crossed with liver-specific NNMT knockout mice or provided nicotinamide riboside to
increase NAD+. Aim 2 will determine that an increased NAD+/NADH ratio supported by ketogenesis facilitates
lipid disposal in response to exercise. HMGCS2 and β-hydroxybutyrate dehydrogenase 1 will be deleted in
livers of mice fed a GAN diet to impede ketogenesis and NAD+ provision. Acute and chronic exercise protocols
will be completed. Impact: This project will lead progress in creating a paradigm shift by advancing our
understanding of how ketogenesis facilitates lipid disposal and informing new therapies for preventing NASH.

Public health relevance
Non-alcoholic fatty liver disease (NAFLD) is the most common chronic liver disease in the United States and it increases the risk of cirrhosis, hepatocellular carcinoma, and cardiometabolic diseases. The proposed research will define how liver ketogenesis actively supports fat breakdown in the tricarboxylic acid cycle and show that loss of this beneficial coupling contributes to the pathological progression of NAFLD. This improved understanding of how mitochondrial pathways coordinate fat disposal will inform new interventions to prevent and treat NAFLD.